Novel Bacteroides fragilis Competition Factor in Carbapenem-Resistant Strains

PROJECT SUMMARY
Within the colon, early life bacterial colonization events favorably influence host health, but simultaneously
establish a vast reservoir for antimicrobial resistance genes. Bacteroides fragilis represents up to 2.5% of the
human gut microbiota and is often found in neonates within the first month of life. B. fragilis is the leading cause
of anaerobic sepsis and deep tissue infections. While long recognized as an antimicrobial resistance threat, an
increasing number of B. fragilis clinical isolates now express high-level resistance to b-lactam antibiotics
including the carbapenems which are considered agents of last resort. Genetic analysis has revealed two distinct
phylogenetic clades of B. fragilis, termed clade I and clade II. Clade II strains exclusively harbor the cfiA locus
which encodes for metallo-b-lactamase (MBL) activity - an antibiotic resistance enzyme for which no available
inhibitors have yet been defined. We have discovered a novel B. fragilis toxin that is specifically expressed in
clade II isolates, termed Bcf1. Bcf1 appears to play a critical role in interbacterial competition between B. fragilis
isolates, positioning this toxin to enable dominance of clade II strains within the B. fragilis niche, expanding the
reservoir for MBL-encoded resistance. The primary goal of this proposal is to examine the molecular mechanisms
by which Bcf1 facilitates interbacterial competition. Our preliminary data suggest that competition may rely on
the ability of Bcf1 to limit nutrient access within the niche. We will explore this through a series of in vitro and in
vivo studies utilizing engineered bacterial genetic variants to discover the protein(s) targeted by Bcf1 and
evaluate the necessity of Bcf1 in inter-clade competition within the B. fragilis niche in a mouse model of colonic
colonization. These studies will benefit from the use of a novel model of B. fragilis vertical transmission in which
the temporal and genetic determinants of niche colonization and interbacterial competition by B. fragilis can be
evaluated in young mice. Through a comprehensive dissection of the mechanism by which Bcf1 ensures the
success of clade II B. fragilis strains, this study has the potential to illuminate a novel mechanism by which
antibiotic resistance to the potent metallo-b-lactam antibiotics is achieved. By focusing on the ecological niche,
these studies may discern critical early events in niche occupancy that are subject to perturbation, or alternatively
highlight novel probiotic-based strategies by which to re-shape interbacterial competition events mediated by
Bcf1 to selectively reduce the prevalence of clade I MBL-expressing strains within the colonic microbiome.

Public health relevance
PROJECT NARRATIVE B. fragilis is a leading microbial reservoir of antibiotic drug resistance, most concerning of which is through expression of metallo-b-lactamases (MBL). At present, there is a gap in knowledge on how MBL expression is preserved within the native colonic niche of B. fragilis. We have identified a novel bacterial toxin that facilitates competition of MBL-expressing B. fragilis. Understanding the molecular mechanisms by which MBL-expressing B. fragilis gain access to and preserve the colonic niche is expected to inform an understanding of how to combat spread of drug resistance.